University of Minnesota Clinical and Translational Science Institute (UMN CTSI)

The National COVID Cohort Collaborative (N3C) is a project that is funded by NCATS to build a central registry of patients who have been tested for COVID-19 or have a clinical diagnosis of COVID-19. The Observational Medical Outcomes Partnership (OMOP) data model is the representational format used in the full N3C repository. This project proposes to develop a COVID-19 data extract from the University of Minnesota COVID-19 Registry by mapping it to the OMOP data model in order to support optimal participation in the N3C. The OMOP format will allow us to contribute all of our COVID-19 patient data at a level of detail necessary to study this disease. The University of Minnesota has developed and maintains a CDR that contains the EHR records and ancillary data for 3M patients from affiliated clinics and hospitals of the M Health Fairview System. The CDR was created in 2012 and uses a proprietary data model developed at the University of Minnesota which has served our researchers well. In 2017, Fairview Health Systems merged with another healthcare organization, HealthEast. As of 2020, the HealthEast EHR has not been integrated into the overall Fairview Epic system and no HealthEast EHR records are available in the CDR. In March 2020, one of the HealthEast hospitals, Bethesda, was designated as the COVID hospital to treat COVID-19 ICU patients for the combined health system. Because of this, only 50% of our COVID-19 patients' data is available in the CDR. In order to serve the immediate needs of our COVID-19 researchers, a process for extracting COVID-19 related data from the HealthEast system into a University of Minnesota COVID-19 Registry has been implemented. The University of Minnesota has signed the N3C data transfer agreement and will begin participation by extracting data from our ACT i2b2 instance to the N3C. However, none of the HealthEast data is incorporated into our ACT i2b2 database. For complete participation, we propose to map the University of Minnesota COVID-19 Registry to OMOP in order to support optimal participation in the N3C. The OMOP data model provides the optimal mapping with the most detail and gives the N3C the most benefits from our data. This approach will also allow all of the HealthEast COVID-19 patient data to be included in a complete extract of all COVID-19 patients across our entire health system to the N3C with data represented at a level of detail necessary to study this disease.

Public health relevance
This project will enhance the University of Minnesota COVID-19 Registry by mapping it to the Observational Medical Outcomes Partnership (OMOP) data model in order to support optimal participation in the N3C. The OMOP format will allow us to contribute all of our COVID-19 patient data at a level of detail necessary to study this disease.